Admin Core

ABSTRACT
Administrative Core: The Administrative Core (AC) will provide the essential infrastructure and guidance to
enable synergy and coordination of the individual research cores, as well as communication with other TMCs,
the larger SenNet Network, NIH, and other NIH-funded mapping initiatives. The aims of the AC include providing
a leadership and management plan for the TriState SenNet TMC, the development and implementation of
Collaborative Pilot and Feasibility Projects and other collaborative activities, the coordination and facilitation of
interactions of the TriState SenNet TMCs cores and projects, and the building of a broad network for interactions
with other SenNet sites and the NIH. An outstanding team of trained professionals in administration,
communications, finance, large data oversight, and research project development will leverage the existing
infrastructure within the University of Pittsburgh (Pitt). The leadership and management team at Pitt will closely
work with the co-Program Directors at Ohio State University (OSU) and the University of Rochester Medical
Center (URMC) and further interact with the entire investigator team at all involved institutions to maximize the
efficiency and success of the projects and cores within the entire TriState SenNet TMC. The overarching goal
of the AC is to maximize synergy among the core teams at all four institutions and create an open and stimulating
environment that ensures and fosters innovative and rigorous science. The AC supports and ensures this overall
goal of the TriState SenNet TMC to identify, map, and functionally characterize the heterogeneity of senescent
cells at single-cell resolution in human lung and heart tissue across the lifespan.